PSE obesity supplement to PA Moves

Project Summary / Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
25-004. Suboptimal health and nutritional outcomes, including obesity, are the result of generational and
historical inequities that have cut across social domains, including housing conditions, financial stability,
transportational quality, and access to educational attainment. For example, for individuals who live in
geographic areas with limited access to quality greenspace or with high levels of crime, it may be difficult to
spend time outside one’s home. Lack of exercise, loneliness, or higher perceived stress all have health
consequences. In fact, more than decade ago, scientists began pointing to ‘systems science,’ as the way
forward in obesity research. By addressing the complex, interrelated forces driving proximal and distal
measures of obesity, we may be able to address rising obesity rates, prevalence, and disparities. While the
parent study, 5R01CA268017, “PA Moves,” is an important intervention trial focused on physically inactive
rural residents, many of the issues participants face around access opportunity cut across the rural-urban
divide. Bringing together the social, educational, and governmental systems on neighborhood, community, and
regional levels is a foundational step to larger policy efforts. Specifically, understanding multilevel (i.e.,
individual, neighborhood, policy) and multisectoral (e.g., housing, city planning, education, healthcare)
approaches can maximize the success of efforts to address key modifiable risk factors. The goals of this
proposed supplement are aligned with NOT-CA-25-004 Administrative Supplements for Assessing Capacity to
Address Obesity for Cancer Prevention and Control. We wish to support early foundational efforts to help form
the scaffolding to address obesity on a larger level. Specifically we will 1) Examine the prevalence of obesity in
the University of Pittsburgh Medical Center (UPMC) Hillman Cancer Center catchment area, with a focus on
the City of Pittsburgh; 2) Carry out an environmental scan of key collaborators and the policy landscape in the
City of Pittsburgh addressing obesity and its determinants, and 3) Convene representatives of the groups to
discuss and report out on the community and organizational readiness to develop and evaluate a whole of
systems approach to obesity including both enhanced obesity care, prevention, and Policy, Systems, and
Environmental (PSE) approaches to both these aspects of obesity.

Public health relevance
Project Narrative Obesity prevalence in the United States has tripled over the last six decades and is associated with an increased risk of thirteen cancers. While numerous efforts have sought to address rising rates, multiple policy, systems, and environmental (PSE) approaches offer promise to addressing this rise, but true whole of systems approaches have been limited. Foundational work is critical to build the foundation to organize, implement, and evaluate such approaches. This supplement will support foundational efforts in three key Pittsburgh neighborhoods, bringing together government and non-governmental agencies, community stakeholders, and researchers to set the stage for a larger whole of system approach to obesity in Pittsburgh, Pennsylvania.